Mechanical Anisotropy in E-cadherin-Induced Polarized Actin Architecture as a Driver of Interfacial Opening and Adherens Junction Formation Between Cells

Project Summary/Abstract
Cadherin mediated cell-cell contact formation is essential for tissue integrity and organization. It has been
proposed that the dynamic reorganization of cadherins and the actomyosin cortex is critical for the opening of
cell-cell contacts. Although disruptions in adherens junctional complex can lead to diseases such as tumor
metastasis and developmental disorders, the mechanisms by which cadherins regulate the mechanical
properties of the actomyosin cortex are not fully understood. Active gel theory suggests that uneven mechanical
stress within the actomyosin network drives flow, which facilitates the opening of intercellular junctions by
depleting the F-actin and reducing interfacial tension. E-cadherin clusters are thought to modulate mechanical
stress within the cortex through two primary pathways: (1) local inhibition of myosin contractility via depletion of
Rho GTPases, and (2) direct mechanical coupling with actin. The current model primarily focuses on the first
pathway, where E-cadherin-mediated downregulation of RhoA-GTP inhibits myosin-II activity at the contact
center, initiating centrifugal F-actin flows. However, this model does not fully explain how E-cadherin clusters
and actin co-localize at the contact rim once a steady state is reached. Therefore, we aim to investigate how the
alternative pathway, involving direct interaction between E-cadherin and actin, modulates actomyosin symmetry
breaking and leads to the dynamic reorganization of the cortical actomyosin network. Previous studies have
identified key mechanical properties of the adherens junctional complex and the actomyosin network, showing
that junctional adaptor proteins such as α-catenin and vinculin form directionally asymmetric catch bonds with
F-actin. These asymmetric interactions suggest that E-cadherin clusters may promote the formation of
anisotropic F-actin polar asters, with (+)-barbed ends oriented toward the center. Since myosin motors generate
contractile forces between antiparallel actin filaments, the arms of these asters can be stabilized by catch bonds
when they coupled to the opposite arm of another aster. Therefore, I propose that chain of E-cadherin clusters,
linked by arms from actin asters, form the basic architecture of the interfacial actomyosin network. This ring-
shaped structure can then expand due to the outward mechanical stress superimposed by local anisotropy and
concentration gradients within the actomyosin network. In this proposal, I will test the following hypotheses to
explore this working model. First, I will examine the mechanical coupling between E-cadherin clusters in close
proximity using a patterned supported lipid bilayer model. Next, I will Investigate the arrangement-dependent
mechanical coupling between E-cadherin clusters by addressing quantification of attractive force and position-
dependent lifetime of E-cadherin clusters. Finally, I will develop a biophysical model, grounded on active polar
gel model, to understand the role of mechanical coupling in interface opening. By addressing these hypotheses,
this research will enhance our understanding of how E-cadherin clusters and actomyosin networks interact to
regulate the formation of cell-cell contacts.

Public health relevance
Project Narrative Despite the fact that altered expression of cadherins is closely associated with various pathologies, including epithelial-mesenchymal transition (EMT)-dependent fibrosis, the precise mechanisms by which cadherins regulate cell-cell contact formation remain poorly understood. The current RhoA-GTP gradient model of interfacial opening does not fully explain how co-localized E-cadherins and F-actin coordinately regulate symmetry breaking in cortical tension. The central goal of this project is to investigate the role of actomyosin mechanical anisotropy, driven by the direct interaction between E-cadherin and F-actin, in cortical tension symmetry breaking and adherens junction formation, providing insights for future tissue engineering and regenerative therapies.